Adventures in the Design and Trial of an Innovative FASD Risk Assessment: Integrating Known Risks with New Measures of Weekly Prenatal Alcohol Exposure, Maternal Mental Health, and Paternal Alcohol

Program Director/Principal Investigator (Last, First, Middle): Cheatham, Carol
Abstract and Public Health narrative of the Phase Summary of the Phase I/II:
Abstract of the Phase Summary of the Phase I/II
Prevention of and intervention in fetal alcohol spectrum disorders (FASD) requires a detailed knowledge
of proximal and distal maternal and paternal risk factors that are associated with specific child traits
common to FASD. In the completed R61 Phase, we created and piloted novel protocols for: 1) interviewing
mothers (with biomarker validation) to determine maternal alcohol consumption on a weekly/monthly basis
across pregnancy to assess their specific contributions to child traits and severity of FASD outcomes; 2)
determining maternal experience with stress, trauma, and mental health status during pregnancy and their
contribution to the severity of effect on FASD diagnostic traits in their offspring; 3) interviewing biological
fathers of the index pregnancy regarding paternal traits that may contribute to the risk for FASD from
exposure to teratogens such as alcohol, other drugs, environmental toxins, and social environment during
pre-conception; and 4) establishing a comprehensive, summary FASD risk score from the above
innovations when combined with other empirically-established risk factors.
The R33 Phase will now initiate an exploration of a multivariate, comprehensive
approach to FASD risk via two applications for better understanding FASD etiology.
In the prospective study, 200 women and as many of their partners as we can consent (estimated to be a
minimum of 100) will be recruited from prenatal clinics, and their offspring will be assessed at six weeks
and nine months post-partum and diagnosed as to their status on the continuum of FASD by pediatric
dysmorphologists and a multidisciplinary team. The second application of the new methods will gather the
new data retrospectively and link the data to two existing cohorts of maternal/child dyads whom we have
followed over time to assess their FASD status and the severity of their physical, neurodevelopmental, and
behavioral traits. Both studies will add new insight to our long-term quest to understand more completely
the respective contributions of a broad range of host, agent, and environmental factors to the etiology of
FASD. This R33 Phase will provide substantial validation of the utility of collecting weekly alcohol use data,
mental health status assessments, paternal information, and FASD risk score innovations via expert clinical
assessment of the offspring of each pregnancy. In developing this more comprehensive approach to FASD
risk, both study phases draw on our existing clinical epidemiology infrastructure, the experience of our
multidisciplinary team, and the participants in existing longitudinal cohorts.
RELEVANCE (See instructions):

Public health relevance
Project Narrative (Relevance) of Phase Summary of the Phase I/II With this research, we will uniquely define the factors contributing to FASD through documentation of the quantity, frequency, and timing (QFT) of prenatal alcohol exposure in each prenatal week, maternal mental health and social support, and paternal factors to further understand what places a fetus, and therefore a child, most at risk for specific dysmorphic features and neurobehavioral problems later in life. By developing empirically-based FASD risk scores comprised of established factors and these novel factors (more frequent data on QFT of prenatal alcohol, maternal mental status, and paternal risk factors) in South Africa, risk-based interventions for men and women can be planned and implemented not only in South Africa but effectively adapted and fine-tuned for United States populations. PHS 398 (Rev. 03/2020 Approved Through 02/28/2023) OMB No. 0925-0001 Page 2 Form Page 2 Program Director/Principal Investigator (Last, First, Middle): Cheatham, Carol - UNCCH DETAILED BUDGET FOR INITIAL BUDGET PERIOD DIRECT COSTS ONLY FROM 04/01/2025 THROUGH 03/31/2026 List PERSONNEL (Applicant organization only) Use Cal, Acad, or Summer to Enter Months Devoted to Project Enter Dollar Amounts Requested (omit cents) for Salary Requested and Fringe Benefits NAME Carol Cheatham Julie Hasken CONSULTANT COSTS Melanie A. Manning, MD $10,000 Margaret Adam, MD $10,000 Omar Abdul-Rahman, MD $10,000 Barbara G. Tabachnick, PhD $ 5,000 Wendy O. Kalberg, LED, MA $ 4,500 EQUIPMENT (Itemize) N/A SUPPLIES (Itemize by category) Software - $350 Lab Supplies -To collect and process the alcohol use biomarker, PEth ($83 per sample) - $14,100 Misc. Supplies - $332 TRAVEL Out-of-State - $3,194 Foreign - $7,872 ROLE ON PROJECT Cal. Mnths Acad. Mnths Summer Mnths INST.BASE SALARY SALARY REQUESTED FRINGE BENEFITS PD/PI 0.60 153,700 7,685 3,071 Research Associate 9.00 90,472 67,854 31,225 75,539 34,296 109,835 39,500 14,782 11,066 TOTAL 10,756 99,079 SUBTOTALS - ~ I INPATIENT CARE COSTS OUTPATIENT CARE COSTS ALTERATIONS AND RENOVATIONS (Itemize by category) OTHER EXPENSES (Itemize by category) Research Data Management and Sharing Costs (RDMC Fee) - $900 CONSORTIUM/CONTRACTUAL COSTS SUBTOTAL DIRECT COSTS FOR INITIAL BUDGET PERIOD (Item 7a, Face Page) 900 I DIRECT COSTS 275,360 $ 451,443I CONSORTIUM/CONTRACTUAL COSTS I FACILITIES AND ADMINISTRATIVE COSTS 22,029 TOTAL DIRECT COSTS FOR INITIAL BUDGET PERIOD $ 473,472 I PHS 398 (Rev. 03/2020 Approved Through 02/28/2023) OMB No. 0925-0001 Page 3 Form Page 4